Therapeutic Angiogenesis in Vascular Medicine III

DESCRIPTION (provided by applicant): Neovascularization of injured tissue is fundamental for its regeneration. Recent studies have indicated an intimate relationship between angiogenesis, vasculogenesis and the repair of injured nerves. Our preliminary data indicate that repair of injured nerves is accompanied by active growth or restoration of the blood supply of the nerves. The growth of new vessels, commonly known as angiogenesis, appears to be a critical component of the healing process of nerves. Our preliminary studies also indicate that sonic hedgehog, a protein previously thought to be important primarily during embryonic life, is also capable of participating in the repair of damaged or ischemic tissues, including nerves. The effect of sonic hedgehog appears to be mediated in part by the restoration of blood vessels which supply nerves, but may also involve effects on endothelial progenitor cells that contribute not only to new blood vessel growth, but perhaps also to the reconstitution of the nerve tissue itself. In this Proposal we will investigate the potential for sonic hedgehog to improve the neovascularization and thereby the healing process of injured nerves and will investigate some of the underlying mechanisms responsible for these effects. Our preliminary data suggests that this may represent a novel therapeutic approach for accelerating recovery of damaged peripheral nerves,. Accordingly, these studies will provide basic mechanistic insights, as well as insights into potentially important novel therapeutics. PUBLIC HEALTH RELEVANCE impairment of peripheral nerve function leads to significant disability. The repair and regeneration of injured nerves involves coordinated angiogenesis and neurogenesis. This application seeks to extend our preliminary investigations into the role of the Hedgehog signaling pathway during functional nerve recovery and to evaluate the potential use of Sonic Hedgehog therapy for accelerating the repair of injured nerves.